Uncovering the rules governing mobile genetic element spread

Project Summary:
Horizontal gene transfer plays a major role in the evolution of microbes and host-microbe interactions. The key
drivers of horizontal gene transfer are mobile genetic elements (MGEs), diverse DNA elements that mobilize
genes directly between and within cells in all branches of life. MGEs, such as plasmids and integrative and
conjugative elements (ICEs) of bacteria, are implicated in the spread of genes important for pathogenicity,
symbiosis, antimicrobial resistance (AMR), and other adaptive functions. While the role of MGEs in many host-
microbe interactions is well known, the factors promoting or constraining MGE spread and microbial host
compatibility are poorly understood. This proposal aims to characterize MGE compatibility at multiple scales,
from interactions between individual MGEs and strains, among all strains and MGEs of a genus, to interactions
in complex microbial communities. We will use plasmids of the well-studied agrobacteria/rhizobia complex as a
model to uncover generalizable concepts on the evolution of plasmid-bacteria-host interactions. Several features
make this system advantageous, including genetic tractability, the ability to control microbiome composition, and
experiments with large sample size. First, we will characterize plasmid incompatibility by investigating the
diversity of replication and transfer loci on all sequenced plasmids of a genus. We will characterize other barriers
to MGE transfer by investigating variation in restriction-modification systems, DNA methylation, and defense/anti-
defense systems across this genus-level group. We will then overlay this information and build a model to
predict, for every plasmid, its compatibility with a given recipient strain. Second, we will investigate how
MGEs and chromosomes co-evolve to maintain compatibility. We will focus on a family of plasmids restricted to
polyphyletic host lineages and extend this model to predict other plasmid or chromosomal loci necessary for
compatibility with these MGEs. We will use both genome reduction (Tn-Seq) and additive (cosmid library)
screens to identify loci determining compatibility. Third, we will investigate factors determining the extent and
frequency of MGE transfer in complex microbial communities. Long-read, methylation-aware metagenomics will
inform on the diversity of MGEs in the disease environment. Hi-C sequencing and/or single-cell fusion PCR will
be used to determine the association of MGEs with specific microbials hosts. The presence of restriction-
modification systems, DNA methylation, and defense systems in members of these communities will inform on
constraints of MGE transfer. Overall, this work will provide a holistic model of constraints on MGE spread and
will shed light on how MGEs and their hosts co-evolve to maintain compatibility.

Public health relevance
Project Narrative Mobile genetic elements (MGEs) can mobilize DNA directly between cells and are implicated in the spread of genes important for pathogenicity and antimicrobial resistance. This proposal will identify and characterize the loci encoded on MGEs and the chromosome that determine whether an MGE can be acquired by a given strain. The goal is to determine the factors promoting or constraining MGE spread and build a model to predict compatibility between MGEs and hosts.